Targeting a human gut bacterial genotoxin via engineered commensal bacteria

Abstract
While microbial therapies have employed toxins and immune agonists as therapeutic payloads against cancer,
there remains a gap in knowledge and technology to reduce tumorigenesis caused by oncogenic bacteria and
their associated metabolites. In line with PAR-22- 085, this multi-PI R01 application aims to co-opt a bacterial
toxin-antitoxin system to address colorectal cancer (CRC) associated with colibactin (hereinafter pks+) bacteria.
An increasing number of people are colonized by enteric bacteria that produce colibactin, which can induce DNA
damage, genome instability, senescence, and carcinogenesis in the host. Clinical studies have linked pks+
bacteria to the high incidence of CRC. Despite efforts to understand the fundamental mechanisms underlying
colibactin-induced CRC, a therapeutic strategy has yet to be developed to target colibactin. Interestingly, pks+
bacteria cope with colibactin-mediated self-DNA damage by synthesizing an enzyme, ClbS, to catalytically
inactivate colibactin in the cytoplasm and confer self-protection. Inspired by prior fundamental studies, our team
displayed the anti-toxin enzyme ClbS on the surface of various E. coli strains to neutralize colibactin at the
interface of microbes and the host. We showed that the surface display of ClbS can prevent colibactin-mediated
DNA damage in cell lines and colon organoids. Importantly, an E. coli model strain engineered to display ClbS
markedly reduces tumorigenesis in a colitis-associated CRC mouse model (DSS/Apcmin) infected with pks+
bacteria. Motivated by our preliminary data, three complementary aims will be performed to demonstrate
translational potential. In Aim 1, the surface display of ClbS will be further optimized to enhance the removal of
colibactin via a combination of computational and experimental approaches. In Aim 2, human organoid models
will be utilized to evaluate the protection efficacy of engineered strains against pks+ E. coli in the presence of a
synthetic polymicrobial community. In addition to quantifying double-stranded DNA breaks, whole genome
sequencing will be used to assess the reduction of colibactin-associated mutational DNA motifs matched to those
in clinical CRC specimens. In Aim 3, a native E. coli strain will be employed to harness its durable engraftment
efficiency in different intestinal compartments in the host. The ability of this strain displaying ClbS to reduce
tumorigenesis will be assessed in a clinically relevant early CRC mouse model. Administration frequency, timing,
and dose will be comprehensively investigated for future clinical translation. This R01 application will be
conducted by an interdisciplinary team with expertise in bacterial engineering (Dr. Li), organoids and mouse
CRC models (Dr. Yilmaz), CRC prevention and treatment (Drs. Chan and Drew), bioinformatics (Dr. Levine) and
statistics (Dr. Baladandayuthapani). While engineering E. coli is not a novel concept, this proposal departs from
the status quo because it targets a bacterial genotoxin with implications for the development of CRC. The long-
term goals are to produce (1) a first-of-its-kind intervention against colibactin-induced CRC and (2) a new tool to
selectively remove microbial products to understand the causality between microbial products and cancer.

Public health relevance
Project Narrative An increasing number of people are colonized by pathogenic gut bacteria producing colibactin, a microbial product/toxin linked to the pathogenesis of colorectal cancer (CRC). The proposed work will develop an innovative platform to reduce the incidence of CRC induced by this toxin. Moreover, the platform will also enable a new approach to selectively remove microbial products (e.g., colibactin) as a means to understand causal relationships between gut microbial products and CRC initiation.